District of Columbia Center for AIDS Research (Admin Core)

PROJECT SUMMARY
The District of Columbia Center for AIDS Research (DC CFAR) is one of 19 NIH-funded CFARs across the
United States that have the shared goal of supporting and promoting multi-disciplinary HIV research at their
institutions. In 2021 at the request of NIH, the DC CFAR developed and coordinated the “CFAR Diversity,
Equity and Inclusion Pathway Initiative” (CDEIPI) to widen the pathway to careers in HIV science for young
scholars from groups underrepresented in HIV science and medicine with an emphasis on racial and ethnic
minorities. With supplemental funding from the NIH to support CDEIPI for three consecutive years from 2021-
2023, CDEIPI grew rapidly with CFARs developing a variety of innovative programs including didactic training,
mentored research experiences, and summer residential programs. Over the initial 2.5 years of the program,
there were >1,300 applicants and >600 participants in 39 CDEIPI programs guided by 206 mentors.
In December 2023, the NIH issued a limited competition funding opportunity to enable CFARs to incorporate
pathway programs into the developmental work of the CFAR program rather than through annual supplements.
This proposal then would support the transition of the CDEIPI CC to the “CFAR Pathway Program Coordinating
Center” (CPPCC) which would be incorporated into the DC CFAR Administrative Core. The Specific Aims of
the CPPCC are to coordinate CFAR pathway programs for students from groups underrepresented in the HIV
scientific workforce, support a national network of HIV scientists and educators to develop pathway programs,
and rigorously monitor and evaluate short- and long-term pathway program outcomes to inform best training
and mentoring practices.
The CPPCC will include an Administrative Core for overall coordination and as the point of contact with NIH, a
Program Core to identify best practices and common challenges for CFAR pathway programs, and an
Evaluation Core to coordinate the monitoring and evaluation of CFAR pathway programs. The added value of
CFAR pathway programs is that they provide HIV research and training opportunities to engage the next
generation of diverse students in HIV scientific careers who can then contribute to ending the HIV epidemic in
the United States.

Public health relevance
PROJECT NARRATIVE This proposal would revise the NIH-funded District of Columbia AIDS Research (DC CFAR) to include the CFAR Pathway Program Coordinating Center (CPPCC) which would coordinate and support HIV research training and mentoring pathway programs for high school, undergraduate, graduate, and postdoctoral students in the national network of CFARs. The CPPCC would expand upon the work of the Coordinating Center for the CFAR Diversity, Equity and Inclusion Pathway Initiative (CDEIPI) in which CFARs developed HIV research training programs for students with an emphasis on persons from groups underrepresented in the HIV-related scientific workforce. The overall goal of CFAR pathway programs is to contribute to the development of the next diverse generation of HIV investigators who can contribute to ending the HIV epidemic in the United States.